ANNUAL LICENSE FOR ACCESS TO NDSR SOFTWARE FROM UNIVERSITY OF MINNESOTA NUTRITION COORDINATING CENTER IN SUPPORT OF THE NCI DIET HISTORY QUESTIONNAIRE

The contractor currently maintains a research level food and nutrient database used in research. This task provides NCI with access to this database allowing NCI to provide an extensive list of nutrients and food components on its public use food frequency questionnaire.